GONADOTROPH ADENOMAS--PREVALENCE AND PHARMACOLOGY

To determine the prevalence of gonadotroph adenomas among "non-secreting" pituitary macroadenoma criteria. Also, to determine if gonadotroph adenomas can be suppressed pharmacologically by either a pure GnRH antagonist or gonadal peptides.